Therapeutic targeting the host hypoxia-response pathway to treat Mucormycosis

PROJECT SUMMARY/ABSTRACT
Mucormycosis is a deadly invasive infection caused by several fungal species belonging to the order
Mucorales. The major risk factors include uncontrolled diabetes mellitus that results in hyperglycemia and
ketoacidosis (DKA), other forms of acidosis, treatment with corticosteroids, solid organ or bone marrow
transplantation, neutropenia, trauma and burns (e.g., wounded soldiers in Iraq and Afghanistan), malignant
haematological disorders and deferoxamine therapy in patients receiving haemodialysis. The infection is
generally acquired by inhalation of spores that are ubiquitous in nature and cause either rhino-orbital (almost
exclusively in DKA patients) or pulmonary (mainly in neutropenic leukemic patients) disease. The treatment
options for Mucormycosis are limited. There are currently no vaccines and only two antifungal agents approved
by the USA FDA to treat this disease. The first is Amphotericin B (AmB) which has serious adverse effects,
including nephrotoxicity, and very limited clinical success. Isavuconazole was recently approved to treat
mucormycosis but it is not superior to AmB treatment. In the absence of surgical removal of the infected focus,
antifungal therapy alone is rarely curative. Even when surgical debridement is combined with high-dose
antifungal therapy, the mortality associated with mucormycosis is >50%. In patients with prolonged
neutropenia or disseminated disease, mortality is 90-100%. Furthermore, since there are no federal
requirements to report fungal infections, the true prevalence of mucormycosis is likely to be much higher than
currently reported. The unacceptably high mortality rate, limited options for therapy and the extreme morbidity
of highly disfiguring surgical therapy make it imperative to look for alternative strategies to treat and prevent
mucormycosis. Our preliminary data suggests that Mucorales fungi engage the host cell hypoxia-response
pathway in order to invade host tissue through the pulmonary epithelium. Specifically, inhibition of this pathway
blocks fungal invasion and increases survival in a mouse model of mucormycosis. In Aim 1, we will examine
the role of ANGPTL4, a high priority downstream effector molecule of this pathway, in the pathogenesis of
mucormycosis and explore the therapeutic potential of blocking the action of this protein. In Aim 2 we will use
single cell RNA-seq to identify downstream transcriptional targets of this pathway that are expressed during
Mucorales infection in lung epithelial cells in vivo. We will then characterize the role of these targets in the
context of Mucorales infection both in vitro and in vivo. In Aim 3, we will evaluate the effectiveness of the novel
pathway targets as adjunctive therapy with antifungal agents in treating mucormycosis. We will use our
clinically relevant murine models to evaluate the efficacy of various agents and modalities, alone and in
combination with current antifungals, to treat mucormycosis. The ultimate goal of the work proposed here is to
develop novel anti-infective strategies to disrupt molecular interactions that are important for disease
progression of pulmonary mucormycosis.

Public health relevance
PROJECT NARRATIVE Mucormycosis is a deadly invasive fungal infection with limited treatment options, no vaccines and a mortality rate > 50%. The major risk factors include neutropenia, malignant hematological disorders, organ or bone marrow transplantation, uncontrolled diabetes, and trauma (e.g., soldiers wounded in battle). This research will lead to novel therapies to treat mucormycosis.